Real-time Volumetric Imaging for Motion Management and Dose Delivery Verification

Project Summary/Abstract
Stereotactic body radiation therapy (SBRT) is one of the most effective, well-tolerated, and cost-effective
treatments. The success of SBRT relies heavily on the precision of dose delivery, due to the typically small tumor
size, the very high radiation dose per fraction, and the sharp dose fall-off outside the target. For those sites
where the tumor moves due to respiration, motion management is indispensable to ensure the high-precision
dose delivery of SBRT. Current motion management strategies are either treating a large area encompassing
the tumor motion range, or only delivering radiation dose within a small window (e.g., a gating window or at the
end of inhale) of tumor motion cycle via indirect and inferior tumor motion monitoring (such as external surrogates
or implanted fiducial markers). In-treatment real-time volumetric imaging is highly desired to enable direct,
accurate, and markerless 3D tumor tracking for better motion management and capture unexpected large tumor
motion for patient safety. The availability and accuracy of in-treatment real-time patient 3D anatomy information
is also essential to the development of more active and advanced motion management technologies, such as
multileaf collimator tracking and 4D treatment delivery. The unpredictable motion change during treatment can
lead to substantial deviation of the delivered dose from the planned dose. Adaptive radiotherapy can compensate
for the dosimetric errors by adapting the subsequent fractions. However, due to the notable changes of
respiration, the pre-treatment imaging cannot provide the patient’s actual in-treatment anatomy to assess the
actual delivered dose for adaptive radiotherapy. In-treatment real-time volumetric imaging is needed to enable
dose-guided adaptive SBRT. Despite these strong needs, real-time volumetric imaging is not currently available
due to the big challenge of reconstructing an instantaneous 3D image from very few 2D projections to meet the
real-time requirement. To fill this clinical gap, we plan to develop a real-time volumetric imaging-based tumor
tracking and dose verification (RITD) system using novel techniques in deep learning, imaging, Monte Carlo
simulation and high-performance computation, and use lung SBRT treatment as a testbed. We will accomplish
the following specific aims: 1) To develop and refine a real-time on-board volumetric imaging and tumor tracking
method; 2) To develop an image correction method and a tumor/multi-organ segmentation method on the
volumetric images; 3) To evaluate the performance of the proposed RITD system and assess its clinical benefit.
The innovation of this study lies in developing new deep-learning approaches to enable real-time on-board
volumetric imaging and build accurate tumor tracking and dose verification capability into cancer radiotherapy.
It has substantial potential to improve lung SBRT treatment outcomes by reducing targeting uncertainty,
improving treatment accuracy and precision, and enabling dose-guided adaptive lung SBRT. It paves the way
for more active and advanced motion management (e.g., truly 4D radiotherapy). The proposed RITD system
may be adapted for other cancer sites; thus, it has far-reaching clinical potential.

Public health relevance
Project Narrative Stereotactic body radiotherapy (SBRT) highly requires precise radiation delivery in the presence of tumor motion to eradicate tumors with highly potent dose while minimizing normal tissue dose to reduce treatment toxicity. Our proposed study aims to develop a real-time volumetric imaging-based tumor tracking and dose verification system for lung photon SBRT that will substantially improve treatment accuracy and precision and guarantee high treatment quality throughout the entire treatment course. This system is expected to revolutionize the current clinical practice of lung radiotherapy, and can be adopted for a wide range of clinical applications and easily adapted for liver and pancreas SBRT.